Improved Annotation of Echinoderm Genomic Features

Computational Component 2: Improved Annotation of Echinoderm Genomic Features
SUMMARY
Echinobase serves as a centralized resource for the most complete and accurate genome assemblies and
annotations for species in the phylum Echinodermata. The effectiveness of the echinoderm research
community is directly impacted by the quality of the genome assembly and annotation data hosted on
Echinobase. A recent survey identified improvements to genome assemblies and gene annotations, including
capturing gene orthologues, as top priorities for the Echinobase user community. Assembling echinoderm
genomes has historically been challenging given the relatively high levels of polymorphism and repetitive
sequence common in these genomes. Recent advances in technologies and algorithms for genome sequencing
and assembly permit significant improvements to the contiguity and accuracy of echinoderm genomes in our
care and this component addresses how this will be achieved. Upgraded genome assemblies along with the
deluge of echinoderm transcriptome datasets warrant the re-annotation of gene models and enable the improved
identification of orthologous relationships, both among echinoderms and also to species outside of the phylum.
This is a significant enhancement of Echinobase because the orthologs identified will serve to contextualize
echinoderm research to a broader community of developmental biologists. Echinobase will also serve as a
venue for easily synthesizing information obtained from high-throughput assays of echinoderm development,
including transcriptome and functional genomics datasets, along with annotations of noncoding regulatory
elements throughout the genome. These efforts will also result in the generation of recommendations for optimal
approaches in the assembly of large polymorphic genomes, which remains a difficult problem, and for
bioinformatic analyses involving echinoderm genomes. This will in turn enhance the capabilities of the
echinoderm community to make genomic inquiries, as well as increase the overall impact of this research. The
types of data housed in Echinobase are most impactful when considered as an ensemble rather than in
isolation; integrating signals from datasets generated by multiple research groups, using orthogonal
approaches, and across species magnifies the significance of any trends identified in a single dataset. This is
especially the case for GRN studies, which must draw on all these types of evidence to support nodes and
linkages. By enabling GRN studies, this component therefore, supports the most impactful research in
developmental biology for this phylum. Efforts to annotate and display this data across multiple types of
datasets, and multiple species, are unlikely to be undertaken by individual investigators and thus only a
focused effort as proposed here, as part of the overall Echinobase, can provide this impactful resource.